Fish oil for HIV- Related Infiamm-aging and Immune Senescence

PROJECT SUMMARY (See instructions): HIV infection is associated with the premature onset of age-associated co-morbidities such as non-AIDS malignancies and cardiovascular disease. These co-morbidities have been linked to persistently elevated serum levels of proinflammatory cytokines that mimic an aging phenotype known as

Public health relevance
RELEVANCE (See instructions): HIV infection is associated with chronic inflammation which can lead to the premature onset of immune aging in middle aged persons. Immune aging can lead to the development of chronic conditions, such as heart disease and cancer. Treatments that reduce inflammation have the potential to reverse immune aging. We propose to test fish oil, a known anti-inflammatory, to reverse immune aging in HIV+ persons.